Biology of Neuroendocrine Peptides

This 30 year Program brings together 5 Projects and 3 Cores from 2 institutions and 4 labs to explore the physiologic and pathophysiologic roles and signaling of receptors and ligands related to corticotropin releasing factor (CRF), a peptide we chemically identified at the inception ofthe Program. CRF is the principal neuroreguiatorof the hypothalamic-pituitary-adrenal (HPA) axis and acts within the brain to integrate endocrine, autonomic and behavioral responses to stressors. Many disorders including anxiety, type 2 diabetes, obesity, drug addiction and depression are associated with perturbations ofthe HPA axis and changes in production or sensitivity to CRF. We have chemically and biologically characterized multiple components of this system including two receptor genes (CRFR1 and CRFR2), a CRF binding protein and three urocortins (Ucn 1, 2 and 3). CRF and Ucn 1 have high affinity for CRFR1;Ucn 1 has high affinity for both receptor types;Ucn 2 and 3 are highly selective for CRFR2. This program has developed and analyzed mouse mutants that are deficient in the receptors and the three Ucns revealing unexpected roles for these peptides in the CNS, endocrine and cardiovascular systems, skeletal muscle and gastrointestinal tract. We continue our focus on stress and several projects are now emphasizing metabolism, namely control of appetite and regulation of insulin secretion and sensitivity. The 3D structure ofthe major binding domains of CRF receptors bound to ligands have been solved by NMR and progress has been made towards solubilizing full-length receptors. New potent and selective peptide antagonists of CRFR1 and 2 have been developed and are being used to probe the physiologic significance and the pharmacologic promise of these important signaling systems. Each ofthe Projects in this Program tests hypotheses relating to CRF and Ucns, and have free access to reagents and models developed within the Program. The Program comprises: Proj 1, W Vale, Project Director (PD): CRF and urocorti and their receptors;Proj 2, J Rivier, PD: Pharmacology of neuroendocrine peptides;Proj 3, S Choe/R Riek, PDs: Structural studies of the interaction between CRF G-protein coupled receptors and their ligands;Proj 4, G Koob/E Zorrilla, PDs: Behavioral significance of neuroendocrine peptides;Proj 5, P Sawchenko, PD: Anatomy of neuroendocrine peptide pathways in the brain;Core A, W Vale, Core Director (CD): Administrative;Core B, K-F LeeAA/ Vale, CDs: Biology;Core C, J Rivier/W Fischer, CDs: Chemistry. Specifying the contributions ofthe CRF family of ligands and receptors to the maintenance of homeostasis and to stress-linked allostasis may improve our ability to manage diseases, including mood and metabolic disorders.

Public health relevance
The CRF/urocortin network mediates endocrine, autonomic and behavioral responses to stress and is perturbed in various mood and metabolic disorders. Clinical trials of native peptides and their antagonists are undenway forthe management of several indications including depression, anxiety, acute congestive heart failure and irritable bowel syndrome. Recent findings of possible roles of this family in insulin secretion and muscle insulin sensitivity reveal potential applications in metabolic disease including type 2 diabetes.